Circuit Modulation in Spinocerebellar Ataxias: Mechanisms and Impact

Project Summary
This proposal outlines a five-year career development plan aimed at guiding the principal investigator to
independence as a clinician-neuroscientist with a focus on translational mechanisms and development of novel
therapeutics for Spinocerebellar ataxias (SCAs).
Applicant: Dr. Srinivasan has completed M.D. and Ph.D. degrees, residency training in neurology, and
fellowship training in ataxia and movement disorders. He has extensive experience in biochemistry and cellular
models, with specialized training in high throughput screening (HTS) and small molecule development. Over the
past year, he has expanded his skillset to include animal models of disease and electrophysiology. His career
development plan is designed to apply this skillset to the study of degenerative ataxias. The outlined plan
includes mechanisms to enhance his training in genetic manipulation of neurodegenerative animal models,
cerebellar electrophysiology, transcriptomics and bioinformatics. He will benefit from continued mentorship via
regular meetings and collaborations. Additional research techniques will be acquired through formal coursework,
workshops, and national meetings. Together, the training plan will provide Dr. Srinivasan with the skillset
necessary for a successful independent research career in translational neuroscience.
Research Plan: The SCAs are hereditary neurodegenerative disorders marked by progressive decline in
appendicular coordination, speech, and gait instability, ultimately resulting in premature death due to cerebellar
and brainstem dysfunction. Prior research has demonstrated that motor phenotypes in several of the most
common SCAs are driven by aberrant firing of Purkinje neurons (PCs), which eventually degenerate. Currently,
there are no approved therapeutics for any SCA, and a mainstay of clinical care is advocating for robust
cardiovascular exercise. While exercise is helpful, the precise mechanisms driving the benefits of exercise
remain largely undefined. Dr. Srinivasan's preliminary data demonstrates that exercise improves PC firing and
rescues motor behavior. Combined with his published work that identified a tool compound that restores proper
electrophysiological activity in SCA1 mouse models, Dr. Srinivasan is now positioned to probe whether exercise
benefits derive from correcting PC firing (Aim 1) or additional pathways. He is also primed to mechanistically link
PC firing to dendritic plasticity and eventual neurodegeneration (Aim 2), an important question in understanding
the clinical ramifications of circuit correction as a therapeutic intervention. Collectively, the proposed studies will
launch Dr. Srinivasan's career as an expert in disease pathogenesis in SCAs and position him to help discover
and develop effective therapeutics for these fatal disorders.

Public health relevance
Project Narrative Spinocerebellar ataxias (SCAs) are progressive, incurable neurodegenerative disorders that result in marked motor decline and premature death due to cerebellar and brainstem dysfunction. This proposal seeks to mechanistically define pathways that can improve cerebellar Purkinje neuron firing in SCAs and link dysfunctional firing to dendritic plasticity and cellular degeneration. The proposed studies will expand our understanding of SCA biology and potentially uncover novel targets for improved therapy.